The Role of J-Domain Protein Interactions with Molecular Chaperone Hsp70

Abstract
Cellular proteins need to fold correctly to obtain a specific three-dimensional structure and maintain it despite
internal and external conformational insults. The importance of maintaining protein structure is emphasized by
numerous human disorders such as neurodegenerative Alzheimer's, Parkinson's, and Huntington's diseases, or
prion disease, all considered protein-misfolding diseases. In all cases, proteins associated with the disease
aggregate in a highly organized manner, forming large insoluble amyloid-like fibrils. The natural defense of the
cell against protein misfolding and aggregation is a network of molecular chaperones, with the Hsp70s serving
as a central hub in this network. Hsp70 chaperones recognize and bind short primary hydrophobic amino acid
stretches, existing in virtually all cellular proteins, which become exposed during protein synthesis, folding,
trafficking, membrane translocation, as well as disaggregation and refolding of misfolded proteins, including
fragmentation of amyloid fibrils. This versatile activity of Hsp70 is regulated and targeted towards specific
processes by a cohort of diverse J-domain proteins (JDPs), obligatory cochaperone partners of Hsp70. The
paradigm is that various JDPs can recruit the same type of Hsp70 via direct interaction of their common J-
domain, and at the same time, the diversity of other domains unrelated to cooperation with Hsp70 defines the
specificity of individual JDPs. This model of JDP-driven specialization of JDP/Hsp70 systems extends Hsp70
biological roles beyond protein quality control to such essential processes as transcriptional regulation, ribosome
biogenesis, mRNA splicing, or mitochondrial iron-sulfur cluster biogenesis. However, how JDP/Hsp70 systems
actually perform so many diverse functions is not yet understood.
This proposal examines a conceptually novel hypothesis that the specificity of JDP/Hsp70 systems can
be determined by how JDP, through interactions other than J-domain, modulate Hsp70 activity directly rather
than by their Hsp70-independent features. More specifically, we aim to investigate molecular and mechanistic
details of a potentially new interaction between the J-domain adjacent region, glycine-rich region, and Hsp70
that emerged from our recent comparative NMR studies of two JDP classes. Furthermore, we will determine the
arrangement and orchestration of all known molecular interactions between Hsp70 and the native dimeric form
of JDP. Our chosen JDP/Hsp70 system is essential in vivo and specialized in amyloid fibril fragmentation and
prion propagation, thus of significant medical relevance. Our experimental framework uses both yeast and
human chaperone systems as well as utilizing a combination of in vitro and in vivo approaches for robust and
comprehensive analysis and interpretations. Revealed molecular details and mechanistic insights will expand
our understanding of JDP/Hsp70 systems, supporting ongoing efforts to develop chaperone-targeted therapies
against misfolded diseases.

Public health relevance
Narrative Human disorders related to protein misfolding include neurodegenerative diseases such as Alzheimer's, Parkinson's, and Huntington's diseases, as well as Creutzfeldt-Jakob prion disease, in which disease-specific proteins aggregate into amyloid-like fibrils. The molecular chaperone Hsp70 and its essential partners, JDP proteins, play a central role in the cellular defense mechanism against protein misfolding and aggregation, with a unique role of class B JDPs in processing amyloid-like fibrils. The proposed study aims to investigate the molecular and mechanistic details of specific interactions between class B JDPs and Hsp70, thereby providing valuable insights for the ongoing efforts to develop therapeutic approaches against such protein-misfolding diseases.